The opposing effects of matrix aging and muscle activity on extracellular vesicle promotion of muscle regeneration

ABSTRACT
Young skeletal muscle displays remarkable resilience following an acute injury event, evidenced by a
robust regenerative response and functional recovery. In contrast, even a relatively minor injury to aged
muscle can result in significant functional impairments owing to compromised regeneration. Numerous studies
have identified muscle stem cells (MuSCs) as a major culprit in the failed healing response of aged muscle.
MuSCs represent a reserve cell population that play a primary role in muscle regeneration. However, with
aging, MuSCs display a myogenic-to-fibrogenic conversion, resulting in fibrosis at the expense of myofiber
regeneration. Although cell-autonomous deficits play an important role in cellular declines with aging, the
contribution of biophysical cues from the surrounding microenvironment has been increasingly appreciated.
Tissue regeneration involves a tightly-regulated and bi-directional communication between stem cells and
their biophysical microenvironment. Elegant in vitro studies have demonstrated that substrates engineered to
mimic the elasticity typical of young, healthy muscle promoted stem cell myogenicity, whereas stiffer substrates
drove stem cell chondrogenic/osteogenic differentiation. In vivo, compositional and physical changes in the
extracellular matrix (ECM) similarly exert deleterious effects on stem cell function. We and others have shown
that age-related alterations in ECM biophysical features contribute to disrupted MuSC lineage specification.
Whereas the bulk of studies to date, including our own, have focused on the direct effects of the ECM on stem
cell responses through mechanotransductive signaling cascades, our latest data suggest a novel role of
extracellular vesicles (EVs) in mediating the effect of the ECM on stem cell responses. We have found that
substrates engineered to mimic the stiffness of aged skeletal muscle promoted the cellular release of EVs that
inhibited MuSC myogenicity. In contrast, EVs released by cells seeded on substrates designed to mimic the
stiffness of young skeletal muscle induced robust myotube formation. Aim 1 studies will investigate whether
and how aging of the skeletal muscle ECM shifts the molecular cargoes of muscle EVs, resulting in
compromised MuSC myogenicity and functional regeneration.
While aging is associated with ECM stiffening, mechanical loading increases tissue elasticity and promotes
ECM remodeling. Exercise has also been associated with enhanced muscle regeneration, though many
questions remain regarding the mechanisms underlying these benefits. Our data suggest that muscle activity
shifts EV cargoes in favor of enhanced MuSC myogenic lineage specification, effects we hypothesize to be
responsive to ECM remodeling. Aim 2 studies will mechanistically interrogate the ability of muscle
activity to rejuvenate ECM biophysical features and the biomolecular signatures of EVs in support of
MuSC myogenicity and functional muscle regeneration.

Public health relevance
PROJECT NARRATIVE A muscle injury often results in persistent functional declines and impaired mobility in older individuals owing in large part to impaired regenerative responses. With the goal of better understanding the mechanisms underlying these declines over time, we will: 1) investigate how aging of the skeletal muscle extracellular matrix (i.e., the scaffolding material that surrounds all cells) alters the ability of extracellular vesicles to promote functional muscle regeneration, and 2) evaluate whether and how muscle contractile activity reverses these changes. Our long-term goal is to develop novel therapeutics to enhance tissue healing in a geriatric population